A STUDY OF SPORADIC NEUROASTHENIA ASSOCIATED WITH EPSTEIN-BARR VIRUS

The goal of this project is to characterize a chronic fatigue syndrome and to ascertain whether Epstein-Barr virus plays a role in its causation. We have identified and are further exploring a series of clinical and immunologic abnormalities in some patients. We have nearly completed a large placebo controlled trial of acyclovir therapy in 27 patients with unusual Epstein-Barr virus serologic profiles. Our desire is to determine whether chemotherapy alters symptoms, virus shedding rates or any of a series of immunologic abnormalities we have observed. Our planned studies in this area involve a heightened focus on individuals whose illness began with well documented acute infectious mononucleosis and on the molecular properties of virus recovered from them.